Chemical, Cellular, and Animal Toxicity Evaluations

Abstract Our laboratory has focused on understanding the mechanisms controlling acellular Hbs oxidative and nitrosafive toxicities in vitro and in vivo. Evidence is accumulating which suggests that reduction-oxidation redox reactions of free Hb and hemoglobin-based oxygen carriers (HBOCs), also known as blood substitutes do occur in vivo with some potentially serious clinical consequences. A primary focus of the research is based on the role of oxidants-mediated changes in acellular Hb under conditions that can mimic ischemia/reperfusion injury. Depending on whether host endogenous reductive mechanisms are employed or not, we will invesfigate Hb oxidative reactions in vivo using rats (ascorbate producing) or guinea pigs (ascorbate non-producing). The role of haptoglobin (Hp) and/or other antioxidant materials in supplemenfing endogenous antioxidant mechanisms will be invesfigated. For the investigation of effects of oxygen carrying HBOCs on cardiac